Neighborhoods, Stress and Cancer Outcomes Across the Cancer Control Continuum: Leveraging ecological theory and geospatial analytics to improve cancer prevention and outcomes (Project LEGO)

ABSTRACT
This application is being submitted in response to “Administrative supplements to advance development of
transdisciplinary and large-scale population science and cancer control research projects.” There is a growing
recognition that cancer risk and outcomes stem from complex, layered systems. Clarifying how contextual and
neighborhood factors influence biological processes associated with cancer risk, the development of cancer, or
outcomes among those living with cancer can significantly inform and advance cancer control and population
science prevention and interventions across the cancer control continuum. Our group and others have been
leading new research that demonstrates linkages between the neighborhoods in which people live, work, and
play, and their connection to behavioral cancer risk factors, biological drivers of cancer, and survivorship
outcomes. Yet, accelerating and advancing research linking neighborhood contexts to biological systems and
cancer requires transdisciplinary team science approaches with multiple interrelated projects. Project LEGO
(Neighborhoods, Stress and Cancer Outcomes Across the Cancer Control Continuum: Leveraging ecological
theory and geospatial analytics to improve cancer prevention and outcomes) brings together an ongoing
partnership between investigators at three regionally located NCI-designated Comprehensive Cancer Centers
(Virginia Commonwealth University, University of Maryland, and University of Virginia). A team of
transdisciplinary scientists from fields in behavioral medicine, geospatial analytics, molecular epidemiology, and
cancer biology have been meeting monthly for over one year to conceptualize and propose a large-scale P01
research proposal. The next phase in our planning will require refinement of our scientific framework and model,
further summarizing the salient mechanisms related to stress-biology and cancer that we aim to investigate,
continued demonstration of collaboration through publication of shared scientific products, development of key
projects that will drive a large multi-institutional research agenda, and the establishment of a community advisory
board (CAB) to help focus our work on meaningful impact within our respective communities. We propose to use
this administrative supplement to help accelerate and advance these goals. Our specific aims are to 1) Develop
a strong partnership model, defining our transdisciplinary team to support the development of a large-scale,
multi-component grant application based on LEGO; 2) Identify a unifying framework or model advancing
synergistic transdisciplinary hypotheses that can be advanced across the set of identified research projects
within LEGO; and 3) Advance collaborative publications using existing data and collect additional feasibility data
in service of the proposed projects. We expect that these activities will culminate in a draft proposal for P01 grant
submission to the National Cancer Institute.

Public health relevance
NARRATIVE This application is being submitted in response to “Administrative supplements to advance development of transdisciplinary and large-scale population science and cancer control research projects.” Our study team has been developing a research initiative called “Project LEGO” (Neighborhoods, Stress and Cancer Outcomes Across the Cancer Control Continuum: Leveraging ecological theory and geospatial analytics to improve cancer prevention and outcomes), which brings together an ongoing partnership between investigators at three regionally located NCI-designated Comprehensive Cancer Centers (Virginia Commonwealth University, University of Maryland, and University of Virginia). We propose to develop a partnership model, identify a unifying framework, and advance pilot/feasibility data and collaborative publications, in support of a planned P01 grant submission to the National Cancer Institute.